Epigenetic Control of the Cell Cycle During Animal Development

Abstract
Accurate replication of the genome during cell proliferation is necessary for normal animal development and
homeostasis. Disruption of the regulation or fidelity of replication contributes to many human pathologies,
particularly cancer. Thus, a complete understanding of the mechanisms governing genome replication is
paramount to human health. Replication of large genomes like that found in human cells requires the initiation
of bi-directional DNA synthesis at thousands of individual locations on each chromosome. It also requires cell
cycle-regulated synthesis of large amounts of histone proteins to package newly replicated DNA into
chromatin. This project will focus on how chromatin assembly and organization influences genome replication
during animal development. The basic building block of chromatin is the nucleosome, an octamer of histone
proteins encompassed by ~147 base pairs of DNA. Most histone proteins within chromatin are synthesized
each S phase of the cell cycle from replication-dependent histone genes, which encode the only eukaryotic
mRNAs that end in a stem loop rather than a poly A tail. The genes encoding all five RD-histone proteins are
clustered in metazoan genomes, and transcription and pre-mRNA processing factors required for histone
mRNA biosynthesis are organized into a nuclear body (the Histone Locus Body or HLB) that assembles at
these gene clusters. We will determine the requirements for the coordinate synthesis of the RD-histone
mRNAs using both biochemical and genetic approaches in Drosophila, with a particular focus on the role that
the HLB plays in histone transcription and pre-mRNA processing. Each core histone protein has an N-terminal
tail that protrudes from the nucleosome core and is subject to a variety of chemical modifications (e.g.
methylation, acetylation, and phosphorylation) that modulate chromatin organization and thus influence all
aspects of genome function, including DNA replication. We have developed a method in Drosophila for
engineering any desired histone tail mutation, providing us a means of preventing modification of specific
histone residues and thus of manipulating chromatin organization in a way not available in any other animal.
This genetic approach will be combined with cell biological and next generation DNA sequencing methods to
determine how chromatin organization modulates DNA replication throughout the entire genome, thereby
addressing a major question in the field. Our Drosophila experimental paradigm permits the in vivo
interrogation of these fundamental processes in gene expression and DNA replication in ways that are
unavailable in other experimental systems.

Public health relevance
Project Narrative Replication of the DNA within our genome requires a highly orchestrated series of molecular events to propagate genetic information during cell proliferation with high fidelity, and thus to suppress the onset of diseases such as cancer. This project will combine a unique genetic strategy in the fruit fly Drosophila melanogaster with sophisticated imaging and molecular biology approaches to determine how the synthesis of histones proteins and their packaging of DNA into chromatin regulates the process and fidelity of DNA replication. Because of the high evolutionary conservation of regulators of chromatin and DNA replication, discoveries resulting from our mechanistic studies in flies will be directly applicable to humans.